ADaPT to Engage: Assessing for Disparities and Potential Targets for Intervention to Engage Acutely Ill Children in Research

Project Summary / Abstract – Administrative Supplement Request
The purpose of this K23 administrative supplement is to support the return to full productivity of Erin Paquette,
MD, JD, MBE following 6 months of leave for recovery from serious illness. Dr. Paquette’s long-term goal is to
become an independent physician-investigator testing interventions in the field of enrollment of children at risk
for health disparities in research. The parent K23 award has supported her training, mentorship, and research
experience towards her ability to compete for R21 and R01 grants supporting intervention studies in this area.
The pediatric literature has not produced consensus regarding under/over enrollment of diverse groups in
research and there is inadequate understanding as to why disparities may exist. The goal of this proposal is to
characterize research participation by children at risk for health disparities (CRHDs) in pediatric emergency
and critical care research and to determine the degree to which modifiable and potentially modifiable factors
relate to participation. The central hypothesis—that CRHDs are underrepresented (losing research benefit) and
overrepresented (risking exploitation) in others and that modifiable factors are the primary drivers of differential
study enrollment—will be evaluated in a mixed-methods study with 3 interrelated but distinct aims: Aim 1: To
prospectively characterize enrollment by CRHDs in pediatric ECC research and to identify factors associated
with enrollment and retention. Aim 2: To elucidate qualitative insights into modifiable and non-modifiable
factors impacting enrollment/retention in pediatric ECC research. Aim 3: To determine which factors are most
associated with successful enrollment of CRHDs. To date, Dr. Paquette has completed the enrollment and
analysis of Aim 1 and completed parent interviews for Aim 2. The proposed administrative supplement will
support qualitative methods team members with expertise in subject interviews, qualitative analysis, data
management to perform interviews of study staff members for completion of Aim 2 and development of the
parent survey for Aim 3. The supplement will also allow for qualitative and quantitative analyses necessary to
complete Aim 2 and Aim 3. The Aim 2 and 3 data will provide important information for development of a
recruitment/retention toolkit to be supported through an anticipated R21 mechanism and a subsequent R01 to
evaluate this intervention in a multisite trial. These funds for qualitative and quantitative methods experts will
enable Dr. Paquette to focus on those tasks necessary to maintain scientific productivity, such as completing
data analyses, writing scientific manuscripts, disseminating findings to scientific audiences, and drafting an
R21 application.

Public health relevance
PROJECT NARRATIVE No change from original award.